Asymmetric nucleosome substrates to advance the study of the histone code

PROJECT SUMMARY
Chromatin function is regulated by histone post-translational modifications (PTMs) on nucleosomes,
which act in concert to recruit chromatin-associated proteins (CAPs) and modulate gene expression. This
integrative signaling mechanism is termed the “histone code”. Recent work by EpiCypher and others has shown
that histone PTM (a)symmetry (i.e., symmetric vs. asymmetric conformation) is an important factor in controlling
CAP interactions, providing a basis for a previously unappreciated layer of complexity underlying chromatin
regulation. Mass spectrometry data shows that nearly half of all nucleosomes are asymmetrically modified,
including those carrying the canonical bivalent PTM signature (co-occurring active H3K4me3 and repressive
H3K27me3) that denotes poised promoters. However, there are currently no available substrates or detection
reagents to study PTM (a)symmetry in vitro or in vivo. Thus, new tools are needed to understand how PTM
(a)symmetry regulates chromatin-CAP interactions, which will enable researchers to fully leverage an
understanding of the histone code to develop next-generation biomarkers and epigenetic-targeted therapies.
EpiCypher is developing a first-in-class toolbox to study how PTM (a)symmetry regulates nucleosome
signaling. The technical innovation of this project is the development of a novel manufacturing method to
efficiently generate asymmetric designer nucleosomes (a-dNucs) at commercial scale. The conceptual
innovation of this project is the application of a-dNucs to drive advances in chromatin biology, including: 1)
uncovering mechanisms of CAP interactions; and 2) developing genomic mapping assays using a novel
recombinant detection reagent. To date, commercial dNuc manufacture has been limited to symmetric dNucs,
as existing methods for generation of a-dNucs are highly inefficient. In Phase I equivalent studies, we developed
a novel strategy that bridges asymmetric histone tail dimers for highly efficient a-dNuc manufacturing. We then
applied these a-dNucs to characterize CAP interactions, demonstrating the role of PTM (a)symmetry in the
histone code. In Phase II, we will generate additional a-dNucs and apply them as substrates for biochemical
assays and for development of first-to-market epigenomic assays that map asymmetrically modified bivalent
promoters in vivo. First, we will generate an expanded set of a-dNucs at commercial scale, including disease-
relevant bivalent marks (Aim 1). Next, we will demonstrate the application of a-dNucs to perform mechanistic
dissection of CAP interactions (Aim 2). Finally, we will leverage a-dNucs to develop a novel detection reagent
that binds the highly studied bivalent promoter signature, then utilize this detection reagent to develop next-
generation genomic mapping assays using EpiCypher’s well-established CUT&RUN platform (Aim 3). These
tools will be first-to-market products to study how nucleosome (a)symmetry impacts chromatin regulation, and
their availability has significant impact potential, driving advances for important clinical applications including
development, aging, cancer and drug discovery.

Public health relevance
PROJECT NARRATIVE The symmetric or asymmetric conformation of histone post-translation modifications (PTMs) on nucleosomes impacts chromatin function and gene regulation. Here, EpiCypher is developing a novel toolbox including substrates and assays for the study of histone PTM (a)symmetry, which will advance clinical epigenetics research by facilitating development of new biomarkers and therapeutics.